CLEK STUDY PHOTOGRAPHY READING CENTER

The Collaborative Longitudinal Evaluation of Keratoconus (CLEK) Photography Reading Center (CPRC) provides objective, independent photographic verification of two important components of the CLEK Study: 1.) the presence, absence, and degree of severity of corneal scarring in all study eyes and, 2.) the rigid contact lens fit (fluorescein pattern) in all study eyes that wear rigid contact lenses, as well for the first rigid contact lens base curve that provides clearance of the corneal apex. This proposal provides documentation of the CPRC's ability to perform these functions with high sensitivity and specificity. This proposal also provides a description of the day-to-day organization of work, quality control and data management procedures required to insure the scientific integrity of the CLEK Study and to insure the orderly operation of the CPRC. Documentation of the capabilities of the proposed CPRC Staff for the performance of the Study in accord with the details of the CPRC Operations Manual and with the CLEK Study Operations Manual is provided.